Culturally Adapted Pain Management for Indigenous Peoples in the Pacific Northwest (CAP-I)

PROJECT SUMMARY/ABSTRACT
The prevalence of chronic pain is higher among American Indian/Alaskan Native (AI/AN) people than any other
group in the United States. Although a number of psychosocial interventions for chronic pain are well-established
as effective, there are no culturally adapted interventions for AI/AN individuals. This proposed study aims to
begin the process of developing a culturally-adapted psychosocial pain intervention for AI/AN individuals at the
Portland Area Indian Health Service – Yakama Service Unit. The K99 phase will focus on the development of
the intervention and the R00 will entail a feasibility randomized pilot trial. During the K99 phase, focus groups
will aid the in the development of a treatment manual, workbooks, and procedures for a culturally appropriate
psychosocial pain intervention (Specific Aim 1). After developing a prototype intervention, focus groups will then
provide feedback to improve the intervention (Specific Aim 2). Specific Aim 3 is to assess the feasibility of
conducting a future randomized controlled trial with the developed intervention from the K99 phase. This
research will provide pilot data for an NIH R01 proposal which will be prepared and submitted towards the end
of the R00 phase. The long-term objective of the proposed Pathway to Independence Award is to support the
applicant in transitioning into an independent research scientist who studies chronic pain disparities and
conducts intervention research in AI/AN communities. The candidate's prior research in chronic pain disparities
in low-income communities in Alabama, community-based participatory research, and chronic pain trials are a
strong match for this current proposed project. With the current project, she will expand her knowledge and
expertise into an important new area of research that has largely been neglected by the research community.
With this project, the candidate will have the mentoring and training necessary for enhancing cultural competency
in working with AI/AN individuals (Training Goal 1), gaining skills in conducting community-based participatory
research with AI/AN communities (Training Goal 2), and fostering skills in the development, adaptation,
implementation, and dissemination in clinical trials (Training Goal 3). Drs. Jensen, Walters, Rhudy, and Fuentes
will serve as mentors and offer expertise in the areas of chronic pain intervention research, cultural adaptations
for psychosocial interventions for AI/AN individuals, tribal based research, and community-based research
methods with AI/AN communities. The University of Washington training environment provides significant
resources and support that would facilitate the development of skills and expertise needed for the applicant to
transition into an independent research scientist. The Yakama Service Unit is strongly committed to this
proposed study and will provide critical support in recruitment, retention, and space for focus groups and
treatment. Because each tribal community has their own values, traditions, and culture, the proposed study will
offer a step-by-step process for culturally adapting chronic pain interventions that may extend to tribal
communities across the country.

Public health relevance
PROJECT NARRATIVE The proposed study will begin the development of a culturally adapted psychosocial intervention for chronic pain for American Indian/Alaska Native (AI/AN) individuals at the Portland Area Indian Health Service – Yakama Service Unit. In the short-term, the study will provide the information necessary for adapting interventions (e.g., AI/AN pain beliefs, treatment preferences, perspectives on chronic pain measures) as well as information on whether it is feasible to conduct a fully-powered randomized controlled trial. In the long-term, the study will provide an evidence-based process for culturally adapting chronic pain interventions for tribal communities and potentially decrease pain disparities by providing effective psychosocial techniques for pain management that decrease pain intensity, decrease pain interference, and increase quality of life.